Caregiving Influences on Attention and Executive Function in Children Born Very Preterm

PROJECT SUMMARY / ABSTRACT
Children born very preterm are at increased risk for deficits in attention and executive function, two domains that
are strongly implicated in long-term health and developmental outcomes. We have not yet identified modifiable
environmental factors that could prevent or mitigate cognitive deficits in very preterm children at school age,
though research with younger children suggests that caregiving quality is a potent protective factor.
Understanding relationships between dimensions of caregiving quality and child attention and executive function
at school-age is critically important as the transition to formal schooling poses new challenges for children and
families. Yet, existing interventions targeting caregiving quality in preterm dyads have exclusively focused on
early infancy and not surprisingly, the positive effects of these interventions are completely washed out by school
age. A wider focus on caregiving as a protective factor for preterm children during the sensitive period
represented by the transition to formal schooling is critical. With funds from our prior awards (R01HD072267;
R01HD084515), we established a cohort of very preterm infants recruited at birth (NOVI Study) and have
demonstrated prospective associations among early caregiving factors (e.g., psychological distress) and child
neurodevelopmental outcomes at age 2. The NOVI cohort was selected for inclusion in the NIH Environmental
Influences on Child Health Outcomes (ECHO) program (UG3OD23347; UH3OD23347) which provided funding
for extensive phenotypic characterization of NOVI children through age 7, including assessments of child
attention and executive function. We additionally collected an observational measure of caregiving quality at the
age 7 visit which was not part of the ECHO protocol and requires additional resources for coding and analysis.
The current proposal aims to code multiple dimensions of caregiving quality (e.g., caregiver sensitivity and
structuring) from the observational caregiver-child interaction task. These new data will provide vital information
that could explain the tremendous variability in child attention and executive function we observe in the NOVI
cohort. Using both new and existing data, this proposal aims to determine (a) child-, caregiver-, and family-
related predictors of caregiving quality and (b) associations between caregiving quality and child attention and
executive function during the school-age period in children born very preterm. Findings from this study will
advance theory regarding the contributions of caregiving quality to the development of very preterm children and
could be used to create interventions to mitigate cognitive deficits in very preterm children during the transition
to school. By pinpointing predictors of caregiving quality, these results could also be used to identify preterm
children and their caregivers who could benefit most from a novel caregiving intervention.

Public health relevance
PROJECT NARRATIVE Children born very preterm are at increased risk for poor neurodevelopmental outcomes including specific deficits in attention and executive function that may limit their long-term health and potential. This proposal aims to understand whether variations in caregiving quality (e.g., caregiver sensitivity and structuring) are associated with attention and executive function outcomes in very preterm children at school age, a critical yet understudied developmental period. The knowledge to be gained from this proposal has direct public health benefits as it could improve identification of preterm children at highest risk for cognitive deficits and provide information regarding modifiable caregiver behaviors that could serve as future intervention targets.